VLP-based Vaccines for Targeting Staphylococcus Aureus β-barrel Toxins

PROJECT SUMMARY: Staphylococcus aureus (SA), including methicillin-resistant (MRSA), is
the most common cause of skin and soft tissue infection (SSTI) in the US. SA causes recurrent
infections, particularly in highly susceptible patient populations with reduced immune function. To
date, no vaccine to prevent SA infection has succeeded in human trials. Meanwhile, the need for
a vaccine continues to escalate, as does the ability of this pathogen to acquire antibiotic
resistance. We have developed a virus-like particle (VLP)-based vaccine strategy to control SA
secreted β-barrel pore-forming toxins. In models of skin infection, a vaccine based on this
approach induces antibodies that prevent infection pathogenesis, spares host immune cells and
limits disease. In this proposal, we aim to evaluate the preclinical potential of this vaccine strategy
against a variety of SA β-barrel pore-forming toxins. We will determine vaccine immunogenicity
in vivo, and efficacy in SA colonization. Our results could lay the groundwork for development of
an efficacious vaccine to prevent SA infection and limit pathogenesis. This vaccine could
significantly improve the health of patients who suffer from SA infections.

Public health relevance
PROJECT NARRATIVE: Staphylococcus aureus (SA) is the most common cause of skin and soft tissue infection (SSTI). SA causes recurrent infections, particularly in highly susceptible patient populations with reduced immune function. We have developed a vaccine strategy to target SA β-barrel pore-forming toxins that drive pathogenesis during infection. We aim to test the immunogenicity of these vaccines in mice, and test their efficacy in mouse models of SA colonization. These vaccines could significantly improve the health of patients who regularly suffer from SA skin infections.